Clinical and Translational Science Award

Contact PD/PI: CRONSTEIN, BRUCE Neil
O. OVERALL – PROJECT SUMMARY
The translation and implementation of groundbreaking biomedical discoveries requires the dynamic coordination
of multi-disciplinary partnerships with diverse expertise, interests, and skills. The New York University (NYU)
Clinical and Translational Science Institute (CTSI) represents an innovative public–private partnership designed
to foster clinical and translational research, adopt evidence-based therapies, and apply scientific discoveries to
transform the delivery of medical care and improve health. The CTSI successfully leveraged a partnership of
institutions with unique and complementary strengths to translate science into better health, including: NYU, a
private research university with a history of public service, substantial biomedical, behavioral, and population
health expertise, and robust education and training programs; New York City Health and Hospitals (H+H), the
largest municipal healthcare system in the United States; Nathan Kline Institute (NKI), a state psychiatric institute
affiliated with NYU; and community organizations representing the richly diverse population of NYC. As the
centralized hub that coordinates and integrates activities across these partners, our CTSI catalyzes research
and facilitates access to essential core services, resources, and expertise necessary to engage in the full
spectrum of clinical and translational research across our partner institutions. We provide educational and
training opportunities for our diverse research workforce. Moreover, the CTSI serves as a nexus for collaboration
between investigators at our partner institutions and the nationwide network of CTSA hubs. We more than
doubled self-identified clinical and translational research at our hub over the past 10 years and established
collaborations between NYU, the schools and colleges of NYU, and H+H to further accelerate the pace and
impact of discovery, development, validation, and implementation across the full spectrum of translational
research. We now propose an array of innovative and evidence-based strategies within the framework of the
strategic domains enunciated by NCATS including: 1) Methods/Processes to streamline regulatory processes,
improve the efficiency, quality, and reproducibility of research and increase the rate of implementation of
research advances; 2) Collaboration/Engagement with communities, patients, providers, and researchers to
elucidate and disseminate best practices and guiding principles of team science to improve translational research
and health outcomes; 3) Informatics to provide a strong and innovative digital environment for subject
recruitment, data management, analysis, discovery, and sharing as well as access to an extensive digital
warehouse with data from electronic health records, epidemiologic studies, clinical trials, multi-omic analyses,
and biospecimens; 4) Integration Across the Lifespan with Community and Patient Stakeholders to engage
diverse NYC communities and special populations across the lifespan; and 5) Workforce Development to
advance our efforts to educate, train, and cultivate the next generation of the translational research workforce.
Project Summary/Abstract Page 302
Contact PD/PI: CRONSTEIN, BRUCE Neil
O. OVERALL –

Public health relevance
PROJECT NARRATIVE Continued acceleration of the pace of discovery has increased the challenge of bringing the fruits of scientific discoveries to our community. The NYU-H+H CTSI supports more rapid translation of scientific advances into medical breakthroughs by partnering NYU's scientific and educational resources with both the largest metropolitan healthcare system (H+H) in the US and our remarkably diverse community. Project Narrative Page 303